A Dietary Intervention to Improve Glucose Tolerance in Adults with Cystic Fibrosis

PROJECT SUMMARY/ABSTRACT
Successes in therapies for individuals with cystic fibrosis (CF) have exponentially improved survival in this
population. There is now a critical need for better understanding of how to promote optimal long-term health in
this newly aging population, which is at high risk for development of glucose intolerance and CF-related
diabetes (CFRD). CFRD is clinically and pathophysiologically distinct from type 1 and type 2 diabetes mellitus,
and it drastically impairs quality of life and survival. Unfortunately, specific factors contributing to CFRD onset
and progression remain unknown. Our preliminary data implicate diet as a precipitating factor in glucose
intolerance in adults with CF. Historical links between body mass index (BMI) and survival in CF have
encouraged the life-long prescription of an unrestricted high-calorie, high-fat diet to meet specific BMI goals.
However, the focus on the quantity of calories and fat has come at the expense of the quality of the diet,
resulting in the widespread consumption of excess dietary added sugars. The impact of the typical high-added
sugar, high-fat CF diet on glucose tolerance has not been rigorously tested. Currently, there is insufficient
research available to enable evidence-based dietary recommendations regarding carbohydrate quality specific
to individuals with CF. The purpose of this study is to determine the extent that excess dietary sugars serve as
a precipitating factor in glucose intolerance in adults with CF and to identify potential underlying mediators.
Based on our preliminary data, we propose that the high-added sugar diets that are typically consumed by
individuals with CF exacerbate a decline in first-phase insulin secretion and insulin resistance by enhancing
visceral adipose tissue (VAT) and other ectopic fat deposition and by promoting an imbalance in systemic
aminothiol redox towards an oxidized state. We will test this hypothesis using a rigorous, double-blind feeding
study. Specifically, we will determine if insulin secretion and sensitivity assessed by a combined hyperglycemic
clamp and glucose-potentiated arginine stimulation test (Aim 1), VAT and other ectopic fat deposition assessed
by magnetic resonance imaging (Aim 2), and systemic aminothiol redox (Aim 3) can be improved over eight
weeks by replacing the typical high-added sugar, high-fat CF diet with a eucaloric low-added sugar, high-fat
diet. We will also assess relationships between the changes in glucose tolerance and changes in VAT and
systemic redox. This study is in line with the recent 2020-2030 Strategic Plan for NIH Nutrition Research goal
of using nutrition to reduce the burden of disease in clinical settings. Successful achievement of our aims,
using a rigorous dietary intervention with gold-standard metabolic testing and imaging, will deliver new
pathophysiological insight into the role of diet towards the development of CFRD. Such data will inform
evidence-based design, with mechanistic support, of dietary approaches and other lifestyle or medical
interventions that may have a sustained impact on the health and quality of life of individuals living with CF.

Public health relevance
PROJECT NARRATIVE Individuals with cystic fibrosis (CF), a life-threatening genetic disease, are enjoying longer lives; however, new research is critically needed to better understand the role of nutrition on long-term health outcomes in CF, including CF-related diabetes. This project will help to close this important knowledge gap in CF by determining if a low-added sugar dietary intervention can improve glucose tolerance by reducing visceral fat and reducing oxidative stress compared to a typical CF diet. The end goal of this study is to improve nutrition standard of care to optimize clinical outcomes and long-term quality of life for individuals with CF.